Early mid-life environmental toxicant exposures and AD/ADRD risk in CARDIA

Project summary
Alzheimer's Disease (AD) and AD-related dementias (ADRD) affect more than 6 million Americans and 55 million
people worldwide. Environmental toxicant exposures from younger age have not been systematically
investigated for their roles in AD/ADRD risk despite limited suggestive evidence for organochlorine pesticide
DDT, organophosphate pesticides, lead, and cadmium. AD/ADRD pathogenesis may take decades to develop
before clinical symptoms, thus the role of mid-life exposures on cognitive decline and brain magnetic resonance
imaging (MRI) patterns may be critical to examine in identifying preventable environmental risk factors. A crucial
mechanism through which these toxicants might act is via epigenetic alterations, alongside processes like
neuroinflammation and oxidative stress. There's also a notable racial disparity, with Black older adults having a
twice as high prevalence of AD as White older adults. This raises questions about the potential interplay between
environmental exposures, epigenetic modifications, and social determinants of health (SDOH). In this proposal,
we will leverage the ongoing NHLBI-funded Coronary Artery Risk Development in Young Adults (CARDIA) Study
to examine the targeted and untargeted exposome and subsequent cognitive decline and brain MRI patterns in
this biracial cohort of more than 5,000 Black and White young adults at baseline (mean age 25 years) with 35
years of follow-up completed. We will repeatedly measure organochlorine pesticides, polychlorinated biphenyls
(PCBs), polybrominated diphenyl ethers (PBDEs), untargeted exposome in plasma, and metals and metabolites
of organophosphate pesticides in urine samples (Aim 1). We will examine exposomic biomarkers for associations
with cognitive decline and MRI patterns that increase the AD/ADRD risk (Aim 2). We will conduct an epigenomic-
wide association study to identify epigenomic biomarkers associated with exposomic biomarkers and integrate
multi-omic (genomic, epigenomic, transcriptomic, exposomic) data with neuroimaging and cognitive function
data to decipher the biological links (Aim 3). Finally, we will examine the role of SDOH (including redlining,
education, poverty, and discrimination) on the associations between exposomic, epigenomic, and AD/ADRD-
related cognitive decline and brain MRI patterns (Aim 4). This project is highly responsive to the request for
application that calls for the quantification of the impact of environmental toxicants on AD/ADRD risk in cohort
studies, particularly exposure in the mid-age from 30-50 years. The findings will inform the scientific communities
and the public about the environmental risk factor of AD/ADRD risk, address health disparities among Black
population, and provide novel exposome data and biological insights for future scientific discoveries.

Public health relevance
Project Narrative This study aims to uncover the long-term effects of early exposure to environmental toxicants on the development of Alzheimer's Disease and related dementias (AD/ADRD), utilizing extensive, longitudinal data from the CARDIA Study. It will employ advanced techniques in exposomic, genomic, epigenomic, transcriptomic data analyses to trace the biological impact of the toxicants and understand their role in cognitive decline and changes in brain structure. The research also seeks to understand the social determinants of health that contribute to racial disparities in AD/ADRD development, striving for a comprehensive view of environmental and societal influences.